CD46 as a Signaling Intermediate in N. gonorrhoeae Infection

Abstract CD46 is a human-specific immunoregulatory protein with signaling and receptor properties in immune cells. Activation of CD46 can lead to a variety of outcomes, ranging from immune regulation to inflammation, depending on the relative levels of the two isoforms. Several viruses and bacteria target CD46 during infection, using it as a receptor or downregulating it in infected cells. N. gonorrhoeae (Ng) interacts with epithelial cell CD46 at multiple levels. Infection via the Type IV pilus directly or indirectly triggers its phosphorylation, alters its trafficking, and causes its secretion. Although is published on the numerous biological phenotypes associated with CD46, little is known about the molecular mechanisms underlying them. We have obtained compelling evidence that the pathogenic Neisseria, N. gonorrhoeae and N. meningitidis, stimulate CD46 processing by Presenilin/[unreadable]-Secretase (PS), a protease complex that regulates many important signaling proteins. Our goal is to understand how Presenilin/[unreadable]-Secretase processing of CD46 affects its signaling activities of host cells, and how these activities relate to infection. We propose a model for this CD46 processing pathway and we propose to test the predictions from this model. We are uniquely positioned for these studies with our tail-specific mAbs and the Presenilin double negative mutant cell line. Our studies will shed light on the host aspect of Neisseria biology. Our findings will also add to the knowledge base of CD46 function, and hopefully shed light on other pathogens/CD46 interactions.

Public health relevance
Project Narrative CD46 is a protein that regulates many immune functions in man. CD46 comes in two main forms, and there is reason to believe that the result of CD46 stimulation depends on the relative levels of the two activated forms. CD46 is also the target for many viruses and bacteria - herpesvirus6, adenovirus, Group A Streptococci, Neisseria meningitidis and Neisseria gonorrhoeae. Our goal here is to understand how Neisseria regulates the activity of CD46 through the Presenilin/γ-Secretase protease. Our hope is that this knowledge will be useful for developing methods to control microbial infections.